Targeting ROS enzymes in myeloid-derived suppressor cell to enhance immunotherapy

A recent breakthrough in treating melanoma patients is the use of immune checkpoint therapy (ICT).
Unfortunately, the majority of patients do not respond to ICT. The limited success of ICT has, in large part,
been due to the presence of a highly immunosuppressive melanoma microenvironment. Myeloid-derived
suppressor cells (MDSCs), including tumor-associated neutrophils and tumor-associated macrophages, are
critical drivers of this immunosuppressive microenvironment which promote tumor growth and evade the
immune system. A major challenge in the identification of MDSCs is that the current phenotypic criteria
using surface markers to characterize MDSCs overlaps with that used for myeloid cells, including
neutrophils, macrophages and monocytes, thus, distinguishing this immunosuppressive subset of innate
immune cells will be dependent upon functional characterization. The immunosuppressive nature of
MDSCs are known to depend upon reactive oxygen species (ROS). MDSC respiratory burst is a major
source of ROS which is primarily produced by the enzymes, myeloperoxidase (MPO) and NADPH oxidase
2 (NOX2). Thus, MPO and NOX2 may be important regulators of the immunosuppressive function of
MDSCs. However, little is known with regards to the contribution of immunosuppressive MDSCs,
particularly the function of ROS producing MPO and NOX2, in melanoma immunotherapy response and
disease progression. This proposal aims to target the respiratory burst pathway in MDSCs to enhance ICT
response and overcome the immunosuppressive tumor microenvironment. We hypothesize that increased
MPO and NOX2 activity contributes to MDSC immunosuppression where the inhibition of MPO and NOX2
decreases MDSC immunosuppressive function enhancing ICT efficacy. In addition, MPO and NOX2
activity may emerge as novel functional markers of MDSC accumulation indicative of an
immunosuppressive tumor microenvironment, and may be used as a predictive marker for ICT response.
This project aims to identify the underlying drivers of MDSCs, specifically, that the immunosuppressive
function of MDSCs is due to the elevated activity of the respiratory burst enzymes MPO and NOX2 which
contribute to ICT resistance. Successful completion of this proposal would confirm that MPO and NOX2 are
clinically-relevant targets and provide the framework for the clinical translation of MPO and NOX2 inhibitors
as adjuvants for ICT to improve treatment response. MPO inhibitors, AZD5904, AZD4831 and Verdiperstat,
are currently being evaluated in clinical trials for neurodegenerative disease. However, their effects in
cancer have not been explored. This work would support the repurposed use of these MPO inhibitors as a
combination therapeutic strategy to enhance ICT response in melanoma.